Spatiotemporal Mechanisms of Olfactory Processing in the Human Brain

ABSTRACT (Administrative Supplement) COVID-19 is a viral disease (SARS-CoV-2) that was declared a pandemic by the World Health Organization on March 11, 2020. The disease has negatively impacted the health of millions of people around the world and is taking a toll on the global economy. The disease has been particularly difficult to contain as it is highly contagious, has a long incubation time (2-14 days) and many carriers of the virus are asymptomatic [1-2]. Initial reports of the disease showed that the symptoms of COVID-19 are fever, fatigue, body aches and shortness of breath [3-4]. However, more recent reports have shown that many COVID-19 patients also lose their ability to smell [5]. Furthermore, reports show that the patients who experience smell loss may otherwise be asymptomatic suggesting that smell loss could potentially be an early indicator of COVID-19 in a subset of the population [5]. These recent findings highlight the importance of studying the relationship between smell loss and COVID-19 to better understand the mechanisms and symptoms of the disorder as well as its potential long term effects. The study proposed here will investigate: 1) the extent to which COVID-19 patients develop smell loss (anosmia); and 2) whether the early presence of anosmia can be used to predict the severity of disease. To invesitgate this urgent question, we will use the well-established 8-item “Brief” University of Pennsylvania Smell Identification Test (“B-SIT”) [6-9] to assess the olfactory abilities in patients with suspected COVID-19 infection who present to the COVID-19 external testing sites affiliated with the University of Pennsylvania.

Public health relevance
NARRATIVE The findings of the study hold potential high importance for determining whether smell loss in patients with COVID-19 is predictive of eventual disease severity. Such findings would have important clinical implications for prioritizing which patients are most in need of urgent hospitalization and earlier, more aggressive treatment.